Non-invasive Estimation of the Arterial Input Function in PET Studies using Whole-Body Physiological Models

Project Summary/Abstract
Positron Emission Tomography (PET) is an imaging modality that can be used to asses many physiological or
pathological process through the use of a variety of specific tracers. Currently, the most important clinical
application is in oncology using the tracer 18F-FDG to detect tumors and metastases and assess treatment
response. PET can be a fully quantitative imaging modality able to accurately measure a physiological property
such as the glucose metabolic rate, blood flow, or various protein distribution in various part of the body.
However, semi-quantitative indexes such as standard uptake values (SUV) are more routinely used in clinical
settings, and even some research settings. They are two main obstacles to use the fully quantitative approach
more frequently. The first one is the need for dynamic scans. The second is the need to measure the arterial
input function (AIF) in order to apply kinetic modeling. This AIF measurement is invasive, and complex,
especially for tracers that are metabolized. The goal of this study is to develop novel methods to estimate the
input function directly from the PET images, including the metabolite correction, when a whole-body scan is
performed, which is often already needed for the research or clinical application. We propose to develop
whole-body physiological models (WBP models) to describe the in vivo distribution, metabolism and elimination
of PET tracers and algorithms to estimate the arterial input function, including the metabolite-correction, non-
invasively using these WBP models. We will apply these new methods to 18F-FDG and a variety of other
tracers, including the radiotracer 11C-PBR28 used to measure inflammation, using retrospective analysis of
existing data and newly acquired data to test and validate the methods. For 18F-FDG we will also apply these
WBP models to improve the quantification of static whole-body scans routinely used in clinical practice by
providing SUV values corrected for variability in the input function, and new semi-quantitative indexes of
glucose metabolic rate more accurate that the SUV-based rates currently used clinically.

Public health relevance
Project Narrative PET is an important imaging modality for biomedical research and clinical practice, with many applications, such as oncology, requiring to scan most of the body of the subject. One of the advantages of PET is that it can be fully quantitative, but this often requires the measurement of the arterial input function, which is invasive, and thus rarely used in clinical practice and not always used in research protocols. This study will develop new physiological models and algorithms to non-invasively estimate the arterial input function, including the metabolite correction, when whole-body scans are performed.